K12 Training for Clinical and Translational Oncology Researchers

Abstract:
A critical requirement to sustain the rapid advances in clinical oncology research that have been made over the
last 20 years is to train and mentor the next generation of cancer clinician-investigators. Individuals who can
write and carry out clinical trials that will promote increasing benefit for cancer patients are a crucial resource
that must be preserved. The objectives of the NYU K12 Program are to provide the protected time which will
foster the creativity, drive, and intellectual skills necessary to produce investigators who will make the key clinical
discoveries in cancer research over the next few decades. We seek to equip scholars with career development
skills that will guide them through productive careers as clinician-investigators. This first-time proposal is based
on a record of training and mentoring outstanding clinical researchers while serving as junior faculty at NYU, the
provision of a strong institutional commitment to support development of clinician investigators, representation
of experienced and motivated medical, radiation and surgical oncologists among the mentors, an emphasis on
informatics and computational biology and critical infrastructure that is part of an institutional Clinical and
Translational Science Institute (CTSI) to leverage the strengths of the greater institution. NYU K12 scholars will
complete training on the responsible conduct of research, general and targeted formal didactics instruction
addressing proficiency in clinical and translational research, Master’s-level training in multidisciplinary clinical
research, specialized course work, training in team science, individualized and didactic training in grant
preparation, exposure to alternative career opportunities, and mentored performance of an innovative high-
impact translational research project. Expectations at completion include publication of 2-3 first and/or senior
author manuscripts and submission of a K- or R-level grant or equivalent. Three scholars yearly will dedicate
75% effort to research and career development activities for up to three years each, supervised by mentors with
extensive and outstanding mentoring experience. A strongly invested K12 Executive Committee and a broad
and diverse program faculty will promote each scholar’s mentoring. Our first aim is to provide personalized
mentoring and didactic training to advance the clinical and translational research careers of our cohort of K12
scholars. Our second aim is to allow the K12 scholars to identify, choose and pursue research opportunities
relevant to advancing the field of clinical oncology. Our third aim is to enable K12 scholars to establish
multidisciplinary clinical and translational research networks and collaborations to ensure the success of their
efforts and promote their careers in clinical oncology research.

Public health relevance
In this K12 proposal we wish to establish a training and mentoring program for junior faculty in oncology specialties including hematology-medical oncology, radiation, surgical, gynecologic, neurosurgical and urologic oncology that will provide comprehensive education, training and mentoring for scholars interested in a clinical research career. We will expand existing programs at the Laura and Isaac Perlmutter Cancer Center (PCC) and leverage ongoing training efforts within the NYU Clinical and Translational Science Institute (CTSI) to create an integrated, full-thickness training, mentoring and follow-up program. Our long-term objective is to recruit the next class of scholars in oncology clinical research that will launch careers in clinical investigation and promote their ability to assume leadership roles at PCC and elsewhere.